CHRONIC TOXICITY STUDY OF CODEINE

The objectives of this contract is to investigate the toxicity and carcinogenicity of codeine (a widely used drug) in rats and mice. To accomplish these objectives, a 104-week chronic study at 3 dose levels plus controls, including an interim evaluation at 65 weeks will be conducted. Additional animals shall be treated for 1, 30, 90, 180 or 365 days and 4 animals per dose/sex/specie shall be sacrificed at one of five time points on those days for plasma collection. The plasma samples shall be frozen and shipped to a designated laboratory for codeine and/or its metabolite deter- mination.